Defining the mechanism of inositol 1,4,5-triphosphate receptor-mediated metastatic liver colonization in colorectal cancer

PROJECT SUMMARY/ABSTRACT
Metastatic progression is the predominant cause of death from solid organ tumors like colorectal cancer but is
poorly understood at the molecular level. While modern systemic therapy has incrementally improved outcomes,
survival in metastatic colorectal cancer remains dismal, with less than 15 percent of patients alive at five years.
Therefore, there is an urgent need to identify and characterize the key genes and pathways that facilitate
metastatic colonization. Using a genome-scale in vivo short hairpin RNA (shRNA) screen, the PI and his
collaborators have identified several putative metastasis promoters including the type 3 inositol 1,4,5-
triphosphate receptor (ITPR3), which mobilizes intracellular calcium from the endoplasmic reticulum. ITPR3
deletion in colorectal cancer cells reduces liver metastatic capacity in vivo, implicating ITPR3 as a key driver of
metastasis. Preliminary data suggest that ITPR3 may allow disseminating cancer cells to overcome physiological
barriers inherent to the metastatic microenvironment, such as the loss of normal extracellular attachment to the
primary epithelial site, potentially through shutting down energetically demanding processes such as protein
translation. In addition, ITPR3 may regulate pro-metastatic non-canonical NF-kB signaling and the associated
transcription factor RELB, which was also identified as a robust metastasis promoter in the shRNA screen. These
studies have led to the hypothesis that ITPR3 is a central coordinator of multiple pathways to support survival
during early and late phases of metastatic colonization. Experiments are proposed to (1) define the mechanisms
by which ITPR3 regulates translation and cellular metabolism through polysome/ribosome profiling, proteomics
and metabolomics, (2) elucidate the mechanism by which ITPR3 controls RELB and non-canonical NF-kB
signaling to facilitate metastasis, and (3) determine whether ITPR3 can be therapeutically targeted using novel
organoids derived from highly metastatic patient-derived xenografts. Successful completion of the proposed work
will improve understanding of the mechanisms underlying metastatic colonization in colorectal cancer and reveal
avenues to develop more effective therapeutic strategies to block metastatic progression. The applicant, Dr.
Ryan Moy, is a Medical Oncology Fellow and member of the Gastrointestinal Oncology Service at Memorial
Sloan Kettering Cancer Center (MSKCC). Dr. Moy has outlined a 5-year career development plan that expands
on his background in molecular biology and clinical training in oncology to acquire vital skills for becoming an
independent physician-scientist. He will perform the proposed studies under the mentorship of Dr. Sohail
Tavazoie, a physician-scientist and leading expert in metastasis biology with a strong track record of training
successful scientists. Dr. Moy will develop new skills in bioinformatics, metabolomics, proteomics and the
generation of patient-derived cancer models. In addition to this training plan and strong scientific background,
the combined institutional environments of MSKCC and The Rockefeller University ideally position Dr. Moy to
successful develop into an independent laboratory-based physician-scientist with R01 funding.

Public health relevance
PROJECT NARRATIVE Metastasis is the overwhelming cause of death in solid organ tumors like colorectal cancer but remains poorly understood at the molecular level. We have discovered a critical role for the type 3 inositol 1,4,5-triphosphate receptor (ITPR3), a protein involved in controlling intracellular calcium signaling, in facilitating colorectal cancer metastasis to the liver. The proposed research will define the mechanisms by which ITPR3 allows colorectal cancer cells to overcome physiological barriers like extracellular matrix detachment to colonize distant tissues and test its potential as a therapeutic target, leading to innovative strategies to block cancer recurrence or progression.